Enhancing State Programs within the NCDA & CS by advancing efforts to maintain Manufactured Foods Regulatory Program Standards, Rapid Response Team, and Food Protection Task Force Programs.

Project Summary – MFRPS
The Manufactured Food Regulatory Program Standards establishes a uniform foundation for the
design and management of the State programs responsible for the regulation of food facilities.
The elements of the program standards describe best practices of a high quality regulatory
program. Achieving conformance with them will require comprehensive self-assessments.
These assessments will encourage continuous improvement and innovation. The goal is to
implement and maintain a risk-based food safety program. The continued enhancement and
maintenance of the program standards will better direct regulatory activities toward reducing
foodborne illness hazards and increase the safety of the food supply.

Public health relevance
Project Narrative - MFRPS The NCDA&CS Food and Drug Protection Division Food Program in submitting the enclosed proposal for funding is to continue their efforts towards building the nationally integrated food safety system as required in the Food Safety Modernization Act (FSMA). The outcome that will be realized is the definition and implementation of processes and systems that comprise a model inspection system. In addition, there will be continuation of the infrastructure building that is required to achieve full conformance with the Manufactured Food Regulatory Program Standards (MFRPS).